FDA FERN Microbiological Cooperative Agreement Program PAR-09-215

Project Summary This project comprises the Michigan Department of Agriculture's effort to further participate in the Food Emergency Response Network (FERN), by providing microbiological testing.The FERN cooperative agreements are intended to target state, local, and tribal FERN labs to provide increased sample analyses in the event of food outbreaks or other large-scale food emergency events requiring surge capacity testing of implicated food samples. These samples could involve foods and/or environmental samples related to foods, and will be collected by Federal, State, or local agencies. Numbers of samples and scheduling of samples will be done by the FERN National Program Office (NPO) in coordination with State/Local lab authorities. Federal or State surveillance assignments will also be a source of samples for lab analysis.

Public health relevance
If chosen to be a participant of the FDA FERN Cooperative Agreement Program, the Michigan Department of Agriculture would commit to analyze up to 500 samples annually (utilizing standardized methods). These samples could be part of surveillance assignments as designated by FERN NPO, food emergency outbreak testing (in coordination with State analytical requirements) or large-scale food emergency event surge capacity (in coordination with State analytical requirements).